Relevance of serum mannosidase resistance to the specificity of oligomannose-targeting antibodies

PROJECT SUMMARY
The glycans that decorate the HIV envelope glycoprotein spike (Env) are categorized nominally as ‘self’
antigens given that they are imparted by the mammalian cell’s glycosylation machinery. However,
glycans of the oligomannose-type found on gp120 are mostly clustered into a patch, creating a ‘non-self’
architecture. This oligomannose patch is vulnerable to recognition by anti-HIV broadly neutralizing
antibodies (bnAbs). Given the potency and breadth of bnAbs to the oligomannose patch, there is great
interest in developing immunization strategies to elicit similar bnAbs.
This project aims to fill a gap in understanding barriers to the elicitation of oligomannose-specific bnAbs.
We and others have recently reported on a soluble mannosidase found in mammalian serum that trims
oligomannosides on glycoconjugates designed to elicit oligomannose-specific antibodies upon
immunization. Such trimming would explain why immunizing with oligomannosidic glycoconjugates
typically yields antibodies that bind well to substructures of oligomannose but that bind with
substantially lower avidity to full-sized oligomannose as presented on Env; the latter typifies the binding
manner of bnAbs that target the oligomannose patch.
In this application, we propose to determine the extent to which serum mannosidase activity is relevant
to the quality of oligomannose-specific antibody responses. Specifically, we intend to construct a
mannosidase-resistant glycoside, thus representing the greatest possible resistance to mannosidase
trimming, and determine the specificity of the ensuing antibody response compared to its mannosidase-
sensitive opposite. The project will take advantage of our published work of a bacterially inspired mimic
of oligomannose that, as a neoglycoconjugate, elicits modest levels of HIV-neutralizing antibodies. We will
investigate antibody responses at the polyclonal serum level as well as the monoclonal level; the latter
should reveal similarities, if any, between the elicited antibodies and existing bnAbs.
In sum, we expect the results of this project to shed light on barriers to evoking antibodies with capacity
to bind the highly vulnerable oligomannose patch on HIV Env. Although the difficulty in eliciting
oligomannose-specific bnAbs is often assumed to stem from B cell tolerance, our preliminary studies
provide evidence for serum mannosidase posing at least an additional hindrance.

Public health relevance
PROJECT NARRATIVE Sugar molecules on the HIV spike constitute a potential target for antibodies that might protect against viral infection; however, synthetic sugar molecules created to elicit such antibodies have so far failed to yield the desired antibodies. Emerging research suggests that the synthetic sugar molecules used in past attempts may be degraded by a naturally occurring enzyme in the serum of mammals upon injection. This project will determine whether immunizing with enzyme-resistant sugar molecules improves elicitation of the desired antibodies, thus providing insight into the extent to which enzymatic degradation prevents elicitation of these antibodies.